Electronic Nose Technology to Predict and Assess Pathologic Response After Neoadjuvant Therapy and Recurrence for Non-Small Cell Lung Cancer

Project Summary
In patients with locally advanced lung cancer undergoing induction therapy, prediction and assessment of
response to therapy prior to surgery remain challenging. Response Evaluation Criteria in Solid Tumors (RECIST)
has been used and validated to assess tumor response. However, the area under the curve for predicting
response using RECIST even with radiomics remains moderate. Although circulating tumor DNA and proteins
(e.g. CA125, CA15.3, Cyfra 21-1) demonstrate moderate to high specificity for therapy response, the sensitivity
of these biomarkers remains variable. Therefore, even when the tumor responded completely to induction
therapy, surgical resection of the affected lobe is necessary. A more-accurate prediction of therapy response
could facilitate reevaluating current treatment strategies by tailoring induction therapy or even omitting surgery.
Additionally, survival after curative-intent therapy is predominantly related to the development of recurrence.
Although we and others have identified clinical risk factors associated with recurrence, such as maximum
standardized uptake value, histologic subtype, lymphovascular invasion, many risk factors can only be
determined only after histopathologic assessment of the resection specimen, which precludes the use of more-
aggressive neoadjuvant treatment. In addition, the median time to recurrence detection is approximately 9
months. This may delay treatment of recurrent disease, contributing to the dismal prognosis for these patients.
This proposal aims to investigate the use of volatile organic compounds (VOCs) in exhalates, through electronic
nose (E-nose) technology, to predict and assess response to induction therapy and identify recurrence after
curative-intent treatment of lung cancer. VOCs are metabolic by-products of cellular metabolic processes that
are altered by the genetic changes in cancer cells. VOCs are delivered in the bloodstream and exchanged in the
alveoli on the basis of diffusion gradients. The close relationship between VOCs, the genomic profile and
presence of tumor would allow for the prediction of response to induction therapy and recurrence through
noninvasive analysis of exhalates through E-nose. This technology can detect the variations in concentrations
and composition of the produced VOCs in relation to the amount of viable tumor remaining after treatment. We
will collect 4 breath samples from 20 patients receiving induction therapy for stage II-IIIB non-small cell lung
cancer. We will compare the baseline VOC profiles of responders (complete or major) to those of non-
responders, as well as the baseline and post-surgical VOC profiles of patients who recurred and those who did
not. The longitudinal samples will be evaluated to assess the percentage response to therapy and evolution of
recurrence. The performance of the E-Nose will be compared to that of radiologic assessment and
histopathologic assessment. This proposal has the potential to directly improve health care and precision
oncology by providing a reevaluation of therapy response and recurrence assessment. Moreover, it may identify
new biomarkers and metabolic pathways which can be explored in future research.

Public health relevance
Project Narrative The accurate assessment of therapy response through the detection of volatile organic compounds, using E- nose technology, could facilitate the detection of responders and non-responders more rapidly, improving cancer survival. Moreover, the early detection of recurrence, using E-nose technology, could increase cancer-specific survival by informing subsequent treatment strategies and follow up. E-nose technology could optimize the use of resources (e.g., drug administration and radiographic follow-up) and advance the evolution toward patient- tailored medicine.